Characterizing the regulatory roles of microRNA on mitochondria in the mammalian CNS

PROJECT SUMMARY/ABSTRACT
Neuronal tissue is the most energy consumptive tissue type of the entire body, and as such, depends heavily on
the health and proper regulation of its mitochondria, its main source of energy. Thus, mitochondrial dysfunction
is linked to a number of neuropsychiatric diseases, including the neurodevelopmental disorder Fragile X
Syndrome (FXS). FXS is characterized by loss of the Fragile X Messenger Ribonucleoprotein (FMRP), an RNA-
binding protein that has been shown to interact with microRNAs (miRNAs) and components of the RNA-induced
silencing complex (RISC). Interestingly, using an optimized Ago-CLIP method that unambiguously identifies
miRNA:target RNA interactions within the RISC, our lab has identified prevalent binding of miRNAs to
mitochondrial transcripts (mt-RNA) in the mammalian forebrain. Though mitochondrial dysfunction in FXS has
been identified, a connection with RISC and targeting of mt-RNA has not yet been explored. This proposal seeks
to further characterize the molecular underpinnings of these observed miRNA:mt-RNA interactions, as well as
their impact in both health and disease (FXS). Specific Aim 1 proposes to use the same optimized Ago-CLIP
method, termed CIMERAseq, to determine the subcellular compartment in which the miRNA:mt-RNA
interactions are occurring, as well as use a targeted approach to identify cell-type specificity of the transcript
interactions. Specific Aim 2 explores the possible functional effect of the observed binding by altering levels of
select miRNAs identified in our data and recording the effect in three ways: i) transcript abundance (via
sequencing and qPCR) ii) protein abundance (via Western blot and BN-PAGE), and iii) mitochondrial function
(via assessment of respiratory function, ATP synthesis, and reactive oxygen species (ROS) production). Aim 2
also uses the same effect readouts to investigate mitochondrial perturbations in a mouse model of FXS (Fmr1
KO). If successful, the proposed specific aims will aid in understanding the role of miRNAs as mitochondrial gene
regulators in the mammalian forebrain, both in health and disease. In addition to completion of the proposed
aims, this proposal outlines a training plan formulated specifically for my long-term goal of becoming a well-
rounded independent scientist. Training received through the course of this fellowship will focus on enhancing
my skills in molecular biology methods, bioinformatic methods, and scientific communication and writing. My
sponsor and university, the Johns Hopkins University School of Medicine, are outstandingly equipped to not only
allow for completion of the proposed experiments but also to provide the resources needed to receive exceptional
training in the areas described. The Biochemistry, Cellular and Molecular Biology (BCMB) program in which I
am enrolled is dedicated to providing an exceptional training environment and will support completion of the
research plan as well as career training opportunities. This fellowship will support not only impactful research
toward understanding miRNA and mitochondria in FXS pathology, but also my development into a capable and
independent neuroscientist.

Public health relevance
PROJECT NARRATIVE The central nervous system relies heavily on mitochondria as one of the most energy consumptive tissues in the body, and mitochondrial dysfunction thereby relates to a plethora of neurodegenerative and neurodevelopmental disorders, such as Fragile X Syndrome (FXS). This study focuses on investigating our finding of miRNA targeting of mitochondrial transcripts in the mammalian forebrain and the possible implications of these binding events in both health and disease, such as altered mitochondrial gene expression which may impact electron transport chain composition and function. If successful, this study will expand our understanding of mitochondrial perturbation during FXS, as well as inform basic molecular biology principles concerning miRNA regulation of mitochondrial gene expression.